CNDD Administrative Supplement for Equipment

PROJECT SUMMARY (from funded parent grant)
The overall goal of the Center of Biomedical Research Excellence (COBRE) in Neurodevelopment and Its
Disorders (CNDD) is to enhance research capacity by enabling outstanding multidisciplinary collaborative
research in neurodevelopmental disorders (NDD) at the Medical University of South Carolina (MUSC). This area
is of importance to the state of South Carolina as the diagnosis rate and proportion of individuals with Autism
Spectrum Disorder (ASD) who have significant cognitive impairments is estimated to be higher than those of the
nation. The specific aims are to: 1) Mentor a strong cadre of early career scientists to become independently
funded investigators in NDD research; 2) Establish sustainable core resources to support modern NDD research
while leveraging institutional investments; and 3) Promote sustainability of the CNDD through creation of
multidisciplinary research programs, rigorous evaluation, strategic improvement, and mission alignment with
other Centers at MUSC and across the state of South Carolina. The Center is led by a multidisciplinary team,
composed of a department chair with extensive experience in molecular neurobiology, an expert in the field of
complement biology, and a clinical psychologist focused on ASD research within the MUSC College of Medicine,
coalescing resources to achieve their overarching objective of building a critical mass of funded investigators
that will allow MUSC to compete for future external peer-reviewed programmatic grant support. This application
highlights four of our most outstanding research project leaders (RPLs) who will benefit from an innovative
multiple source mentoring plan which features both internal and external mentors. We anticipate each of these
RPLs to transition to independent NIH funding within the first three years of the project. The CNDD also includes
three Cores, including an administrative core, that will support not only the RPLs but also NDD investigators
throughout MUSC. Scientific cores include the: 1) Genomic and Bioinformatic Core, which will provide technical
assistance, computational infrastructure, and training opportunities, and 2) Mouse Behavioral Phenotyping Core,
which will provide access to and training in behavioral analyses of mice. Additionally, the CNDD will foster
collaborations among NDD researchers by promoting interdisciplinary scientific exchange through our
enrichment activities and build research capabilities through our Pilot Project Program. With NIH and institutional
support, the expansion of research capabilities, development of RPLs, and promotion of integrative,
multidisciplinary NDD research programs, the proposed CNDD will substantially enhance basic, translational,
and clinical research at MUSC. Together with key institutional investments across the state, the CNDD will enable
the formation of a sustainable, thriving hub of world-class research in neurodevelopment and its disorders in
South Carolina.

Public health relevance
Project Narrative There will be no change in the parent grant resulting from this proposed supplement. Common neurodevelopmental disorders (NDDs), including autism spectrum disorders, attention-deficit and hyperactivity disorder, intellectual disability, seizure disorders, and traumatic injury to the developing brain all have major social and economic costs associated. This initiative will establish a center of research excellence in Neurodevelopment and Its Disorders in South Carolina that will ultimately improve the health and well-being of individuals diagnosed with NDDs.